Integrative Single Cell isoform and chromatin accessibility Mapping of Chronic Opioid Exposure in Cognitive Brain Areas in HIV

Opioid driven exacerbations of neuropathological events and alterations in HIV transcription contributing to HIV
associated CNS dysfunction are well-reported. Despite years of continuous suppressive antiretroviral therapy
(ART), latent HIV persists and finds sanctuary in many of the same brain regions involved in opioid use disorder
(OUD) suggesting interactions between HIV and opioids in brain cells. However, there is a sizeable gap in our
knowledge on how OUD impacts cellular responses and viral persistence in HIV-infected brain on ART in humans
or relevant model organsims. This administrative supplement proposal seeks to generate new topographical
data sets from the parent award and evidence at single cell resolution across the hippocampus, a brain region
known for predilection for HIV persistence and OUD in non-human primate (NHP). These data will provide an
unprecedented cellular landscape of multiple modalities that can be harnessed to develop strategies to limit viral
persistence and restore and retain optimal brain health in people living with HIV. In our published and preliminary
work we have developed innovative single-cell approaches including Single-cell isoform RNA sequencing
(ScISOr-Seq), which enables single-cell long-read RNA sequencing of polyadenylated RNAs across thousands
of single cells. In concert these novel sequencing and computational methods, along with ScATAC-Seq for
chromatin accessibility, will permit the mapping of cellular gene expression, open chromatin regions, isoforms
and the detection of SIV across single-cells of hippocampus. Recent literature supports the presence of HIV in
the brain and more specifically in microglia and astrocytes present within the hippocampus. Importantly, this
brain region is also involved in associative learning processes for OUD. Moreover, our prior studies in rodent
hippocampus have laid the groundwork for the proposed studies by establishing the regional and cell-specific
distributions of opioid peptides and receptors as well as related signaling molecules, and how these distributions
are impacted by sex, stress and opioid-associated learning. Using new cutting-edge single-cell mulitomic
integrated genomics, we propose in this supplemental application to generate multi-dimensional single-cell
data sets and define the relevance of such observations in a controlled SIV infected NHP model with and without
a different opioid of documented chronic morphine exposure for comparison with the parent study evaluating
oxycodone. We also propose to validate any changes observed in single-cell expression in select genes using
in situ hybridization. We propose to achieve these goals under the following specific aims: Aim 1. Generation
of genome-wide single-cell transcriptomic profiles in the hippocampus in a controlled setting of SIV infection of
NHPs monitored on ART and exposed to chronic morphine. Aim 2. Establish genome-wide single-cell
epigenomic profiles of the hippocampus in the groups examined in aim 1.

Public health relevance
RELEVANCE Through an interdisciplinary team this proposal will generate single-cell type nomenclatures of brain regions of interest involved in persistent HIV and chronic opioid exposure. A combination of innovative single-cell RNA sequencing tools, proximity and spatial mapping studies and computational analysis will reveal cell-type specific molecular rearrangements and synergistic interactions of HIV and opioids.